ULTRASOUND VS VIDEOFLUOROSCOPIC IMAGING TO DIAGNOSE OROPHARYNGEAL DYSPHAGIA

During the past year we have focused our ultrasound and videofluoroscopic studies on patients with progressive supranuclear palsy, post-pallidotomy Parkinson's disease, and corticobasal degeneration. Follow-up studies were performed on patients with inclusion body myositis and polymyositis in preparation for long-term descriptions of these conditions. Considerable effort has been spent to develop a computer program that digitizes and analyzes the videofluoroscopic images. This model allows us to examine the timing of specific swallowing events and the range of motion of specific structures in sequential and discrete swallows. Post-Pallidotomy Study Twelve patients who underwent bilateral pallidotomy and were evaluated at NIH received comprehensive oral motor and swallowing evaluations 1 month before and 2 months following the procedure. Intrasubject comparisons were made to determine whether swallowing severity and function swallowing changed after surgery. Findings revealed great variability across the evaluation parameters, with more patients who worsened on the pharyngeal and esophageal phases and no difference on the oral findings. In spite of changes in the instrumental swallowing studies, 10 out of 12 subjects did not evidence any category change in the severity and functional outcome rating scales. This study suggests that pallidotomy does not conclusively benefit subjects with respect to either oral motor or swallowing ability.